Administrative Core

The success of this U19 will be critically dependent on its scientific and administrative leadership. These two essential components come together in the Administrative Core which will be led by Dr. Claire Fraser, as PI and Administrative Core Director, along with Drs. David Rasko and Owen White, as team PIs. The leadership team that has been assembled for this U19 application has a long-standing track record of success and innovation in the application of large-scale DNA sequencing and analysis to the study of pathogens, vectors of disease, and the human microbiome. Together, they contribute more than 60 years of experience and more than 250 peer-reviewed publications in the field of genomics that have been collectively cited more than 86,000 times. The Administrative Core will be responsible for (i) maintaining oversight of all expenditures related to this contract, (ii) integrating research efforts across multiple Research Projects and Cores to maximize synergies, (iii) monitoring Research Project progress to identify any technical or administrative issues that could negatively affect project completion in a timely way, (iv) interacting with Core Directors to anticipate delays that could negatively impact the Research Projects, (v) establishing and interacting with the Steering Committee, (vi) working with the GCID Training Leader to establish and promote workshops and fellowships to further expand genomics expertise in the infectious disease community, (vii) developing a robust Supplemental Research Projects program to bring state-of-theart genomics approaches to bear on high priority research questions in the infectious disease arena, (viii) facilitating communications within and outside of the GCID, and (ix) participating in annual programmatic meetings organized in collaboration with NIAID as well as in internal research meetings to review progress on this U19 award.

Public health relevance
There is a critical need to find new ways to diagnose and treat infectious diseases around the world. The proposed research in this U19 award will use state-of-the-art genomics approaches to study a variety of high-priority pathogens to better understand how they cause disease in infected individuals. This Administrative Core will provide general oversight to ensure that all projects are completed as intended.